Racial/Ethnic Disparities in ADRD Risk: The Impact of Social Relations-Administrative Supplement for Increased Costs

Increased Costs Supplement- Racial/Ethnic Disparities in ADRD Risk: The Impact
of Social Relations
This application for a NIA Administrative Supplement is requested to address the
unprecedented cost increases arising from the two-year delay that followed the COVID-
19 mandatory face-to-face data collection shutdown. We note that there has been no
change in the original funded scope of the project Racial/Ethnic Disparities in ADRD
Risk: The Impact of Social Relations (R01AG057510). Despite the delay, no intervening
research has reduced the importance or uniqueness of the proposed study, which
provides an unprecedented opportunity to advance the scientific study of the ways in
which cross-sectional and longitudinal patterns of social relations link with disparities in
ADRD risk. The specific aims are to: 1) Examine secular trends in social relations and
health by race/ethnicity in two adult lifespan regionally representative cohorts; 2) Identify
aspects of social relations that have the greatest effects on ADRD risk among blacks,
whites and Arab Americans in mid- and late- life; 3) Identify longitudinal associations
between social relations across the life course and ADRD risk among blacks and whites.
This supplement is submitted to preserve the integrity of the originally approved
objectives, purpose and expected overall impact of the study. The two-year COVID
delay hit this pioneering study especially hard and has been financially devastating. We
capitalize on an existing longitudinal cohort study of detailed social relations over ~30
years in a diverse lifespan sample (i.e., from age 8 to 93 in Wave 1). Adding cognitive
and genetic measures, as well as extending racial/ethnic group comparisons to include
Arab Americans in a new regionally representative sample (age 35+) provides a novel
opportunity to study modifiable factors in midlife for ADRD risk. Findings will provide key
information to develop strategies using the influential resource of social relations to
reduce disparities. Further, the proposed study sets the stage for a newly representative
longitudinal study of racial/ethnic disparities in ADRD risk.

Public health relevance
Project Narrative Establishing how early and mid-life social relations are associated with ADRD risk in different racial/ethnic groups risk provides an innovative, cost effective opportunity to identify modifiable factors in midlife for ADRD risk. This project will capitalize on an existing longitudinal cohort study of detailed social relations over 30 years in a diverse lifespan sample and add cognitive and genetic measures, as well as extend racial/ethnic group comparisons to include Arab Americans in a new regionally representative adult sample in metro-Detroit. Characterizing how social relations vary as a function of race/ethnicity and clarifying unique links to ADRD risk will advance the field in terms of theory and intervention.